Molecular Mechanisms for Carbohydrate Presentation to CD4+ T cells by MHCII Pathway

Project Summary/Abstract
Most pathogenic bacteria express surface carbohydrates called capsular polysaccharides (CPSs). CPSs are
important vaccine candidates given that they are located on the outermost surface of bacteria and have distinct
structures. These two features make them easily accessible and distinctly recognizable by immune
surveillance, therefore resulting in the production of CPS-specific antibodies by B cells. To induce a CPS-
specific adaptive immune response (i.e., T cell-mediated B cell response), CPSs are conjugated with carrier
proteins, and the conjugation products are called glycoconjugate vaccines. Due to insufficient understanding of
their immune activation mechanisms, current glycoconjugate vaccine strategies have reached saturation and
are largely modifications of past empirical conjugation methods. The production of the current generation of
glycoconjugate vaccines is based on trial and error and does not make use of specific scientific knowledge to
maximize stimulation of critical immune cells (i.e., helper T cells) involved in producing protective IgG
antibodies. A new perspective on carbohydrate-based vaccine research is much needed. With the potential of
establishing a new paradigm, our previous discovery and preliminary data demonstrate that the mammalian
CD4+ T cell repertoire contains a population of T cells that recognize carbohydrate epitopes of glycoconjugate
vaccines, called Tcarbs. Building on our previous mechanistic work, we propose establishing a platform to
design and develop structurally defined glycoconjugate vaccines optimized for their immunogenic and
antigenic components to elicit protective immunity consistently and effectively. This proposal also addresses
another key parameter controlling the immunogenicity of conjugate vaccines, which is to identify the immune
correlates of protection induced by glycoconjugate vaccine immunization. In clinical practice, improving on
measuring CPS-specific antibody titers and the in vitro opsonophagocytic activity as immune correlates of
protection is an essential milestone to achieve for the reliable prediction of clinical efficacy. We propose to
identify key helper T cell populations that are essential for vaccine efficacy as a new immune correlate of
protection. Exploiting CPSs from two highly pathogenic Streptococcus pneumoniae (Spn) serotypes—Spn3
and Spn14—and building on our published and unpublished preliminary studies, we will establish a new and
broadly applicable conjugate vaccine platform and characterize immune responses that result from these
vaccines through two specific aims. Aim 1: Establish a knowledge-based conjugate vaccine platform
composed of endolysosome-cleavable polypeptide chains chemoenzymatically conjugated with CPSs. Aim 2:
Isolate and functionally characterize human Tcarb clones for their ability to induce protective humoral immunity

Public health relevance
Project Narrative Capsular polysaccharides (CPSs), by which most pathogenic bacterial surfaces are decorated, have been used as the main components of glycoconjugate vaccines against bacterial diseases in clinical practice worldwide. Due to inadequate understanding of how the immune system interacts with these complex vaccines, their design and production have often been empirical, yielding poorly characterized, heterogeneous, and variably immunogenic vaccines, with poor immune responses in high-risk populations such as the elderly and patients with weak immune systems. Through the mechanistic knowledge attained in this project, we propose to establish a new-generation vaccine development platform to produce knowledge-based vaccines that are target-specific, structurally designed, highly immunogenic, and protective, produced at much lower cost and allowing much wider use on a global scale than current vaccines to control or eliminate a wide variety of infectious diseases.